The role of RNase L in kidney function

Acute kidney injury (AKI) is an abrupt loss of kidney function from various causes, which may lead
to several complications, including metabolic acidosis, hyperkalemia, uremia, increased
extracellular fluid volume, and death. Exogenous administration of epidermal growth factor (EGF)
has been found to enhance regeneration and repair renal tubule cells and accelerate the recovery
of renal function in post-ischemic and nephrotoxin-induced AKI. On the other hand, activation of
the EGF receptor (EGFR) also contributes to development and progression of chronic kidney
diseases (CKD). Clearly, the activation of EGF/EGFR plays an uncertain role, as it can be either
beneficial or detrimental to renal function after AKI. A better understanding of its regulation in the
kidney is, therefore, of importance. In this study, we hypothesize that RNase L is a very
important regulator in renal function, under basal circumstances, by permitting ADAM10-
dependent tubular EGF secretion, which regulates normal kidney development and growth.
In the context of AKI and tubular injury, these same pathways are essential for repair, but
need to be appropriately downregulated to prevent the transition of AKI to CKD. The
hypothesis is based on the results we recently obtained that 1) kidney size was significantly
reduced in RNase L knockout mice compared to wild-type mice, which was more pronounced
after aging; 2) urine EGF is completely abolished in RNase L knockout mice; 3) RNase L mediated
the expression and maturation of A Disintegrin and Metalloproteinase Domain 10 (ADAM10), a
transmembrane metalloprotease responsible for the shedding and releasing of the EGF precursor
in the kidney; and 4) RNase L knockout mice were recovered much faster than RNase L wild type
mice from folic acid (FA)-induced AKI through activation of the PI3K/AKT pathway. The specific
aims are to investigate the molecular mechanisms by which RNase L regulates the EGF excretion
in urine and the role of RNase L in kidney function under normal and pathological conditions and
explore whether RNase L is involved in AKI to CKD transition. Our study will provide novel insights
into how RNase L regulates the homeostasis of the EGF family of ligands and activation of the
receptors, which are vital in renal development, aging, physiology and pathophysiology. Most
importantly, the project will offer a unique opportunity for more undergraduate students
to be trained in the disease-related basic sciences.

Public health relevance
The objectives in the proposed studies are to investigate the role of RNase L, an interferon inducible enzyme, in kidney function.